UTMB Women's Health Research Scholars Program

PROJECT SUMMARY/ABSTRACT
The goal of the UTMB BIRCWH program, now entering its 20th consecutive year, is to launch junior faculty Scholars into successful careers as independent researchers with a focus on women’s health or sex as a biological variable. Our program has been highly successful with former Scholars obtaining over $79 million in subsequent grant support as PI or MPI. With generous support from UTMB, we are requesting funds for a 5thcycle to support 4 assistant professors for 2-3 years each, for a total of 8 Scholars over 5 years. We will continue
to recruit Scholars internally and externally, using a tiered pipeline that includes 6 other institutions within the University of Texas system. The Scholars will be guided by at least 2 of 26 participating Senior Mentors working in inter-professional teams built from existing collaborations in areas of strength on our campus, such as reproductive health, aging, infectious diseases, and new to Cycle V, cancer prevention. Our successful collaboration with UT MD Anderson Cancer Center will also continue to offer Scholars additional exciting research opportunities. All Senior Mentors have extensive publication records in women’s health or sex as a biological variable, strong external funding as PI (average of > $2 million/year), and demonstrated mentoring
histories. In response to alumni feedback, Cycle V Scholars also will be paired with recent BIRCWH graduates, who will act as “Peer Mentors” to help them navigate and optimize their experience in the program. Scholars will participate in a curriculum designed to prepare them for independence through didactic trainings and structured mentoring. Once appointed, they will make Individual Development Plans that include all required curricular activities and tailor the optional portions of the curriculum according to their self-assessed needs. Innovative
additions to the curriculum include a new “NIH 101” course that overviews the NIH grant application process and a mock study section that allows Scholars to learn how NIH reviewers judge and score grant applications. A new annual regional symposium will also be held in conjunction with the Tulane and University of Colorado BIRCWH programs to allow Scholars from the 3 programs to interact and collaborate. Finally, Cycle V Scholars will have access to several new optional trainings that focus on topics ranging from community-engaged research to team
science. Ultimately, all Scholars must demonstrate competence in 10 educational objectives that define the fundamental knowledge, skills, and attitudes of an accomplished investigator, and successfully compete for independent funding. An evaluation of the Scholars, Mentors, program leadership, and program processes will be conducted annually by a 6-member Advisory Committee and 2 external advisors. In summary, renewal of this highly successful program will enable our junior faculty to launch independent careers and make important contributions to women’s health research.*

Public health relevance
The UTMB BIRCWH program launches assistant professors into successful, independent research careers in women’s health and sex differences through a combination of didactic trainings and structured mentoring. Junior faculty recruited to the program come from diverse research disciplines and are guided through the program by senior faculty mentors with impressive publication records in women’s health, strong external funding as PI (average of > $2 million/year), and extensive mentoring histories. Our program’s ultimate goal is to increase the number of highly skilled researchers who conduct interdisciplinary research that improves the lives of women across the lifespan.